Impact of Diet on Intestinal Microbiota-Host Dynamics

The human gut harbors a dense and complex community of microbes known as the intestinal microbiota. A
disrupted or dysbiotic microbial ecosystem has been connected to several diseases including inflammatory
bowel diseases, metabolic syndrome, and colon cancer. Therapeutic manipulation of the gut microbiota has
broad implications for human health. However, the abundance of bacterial strains that reside within an
individual is largely stable over time and can be difficult to alter in a predictable, robust, and reproducible
fashion. Fecal microbiota transplants are being increasingly used to repair a dysbiotic microbiota, however, the
fate of the introduced strains is unpredictable and largely individualized (i.e., influenced by the recipient's
microbiota). If microbiota reprogramming is to become an effective therapy for a broad range of diseases, a
better understanding of the factors that control entrenchment of therapeutic strain integration and the role of diet
in the reinforcement of new strains is critically important. In Aim 1, microbiota accessible carbohydrates
(MACs), powerful levers on microbiota composition and function, will be used to elucidate the mechanisms by
which exogenous bacterial species entrench within an established microbiota. Furthermore, new environmental
niches will be established through novel dietary carbohydrates to replace pathogenic bacterial strains with
commensal isogenic strains. State-of-the-art synthetic biology tools and imaging will be employed to quantify
the biogeographical location of newly entrenching strains within the colon. In Aim 2, microbes and genetic loci
will be isolated from the microbiomes of hunter-gatherer populations and cognate polysaccharides will be
identified. Since the diet and carbohydrate utilization enzymes encoded within the microbiota of traditional
populations is distinct from that of US residents, these pre-industrialized microbiomes possess a large collection
of carbohydrate active enzymes not present or exceedingly rare in the Western world. Isolation and utilization
of unique MACs will be tested to enable engraftment of therapeutic strains that have been engineered to utilize
these carbohydrates. Whether using multiple privileged MACs is an effective strategy to entrench and control
the abundance of multiple species independently within multiple established microbiotas will be tested in a
humanized mouse model (mice harboring a human microbiota). This proposal establishes a new paradigm for
reprogramming a dysbiotic microbiota, which makes possible the robust and reproducible entrenchment of
exogenous bacterial strains. The ultimate goal of this strategy is to enable stable incorporation of new species
and functions that could be tailored to an individual's specific microbiota and disease state.

Public health relevance
Project Narrative A dense and complex community of microbes resides within each person's gastrointestinal tract that plays many important roles in our health, including aiding in our absorption of energy and nutrients from the foods we eat. Alterations in composition of the gut-resident microbial community are associated with certain disease states, such as obesity and inflammatory bowel disease. The goal of this research project is to understand the principles that underlie bacterial strain invasion into the microbiome, to enable rational reprogramming of gut microbiome composition and function, enabling the treatment and prevention of a variety of human diseases.